CLINICAL PSYCHOPHYSICS OF THE VISUAL SYSTEM

The visual function of patients with ocular diseases or lesions in the visual pathways and of normal subjects is measured by psychophysical techniques. The data obtained are correlated with those obtained by electrophysiological tests of visual function. The results will contribute to the diagnosis of ocular and neural disorders that affect vision and are needed to characterize their nature and evolution. They are also valuable in the assessment of the effect of treatment regimens on the outcome of these disease.